Learning alerting models for clinical care from EMR data and human knowledge

Abstract
Medical errors are more broadly defined as adverse clinical events that are preventable. Studies
show that medical errors remain one of the key challenges of health care and recent literature
ranks medical errors as one of the leading causes of death in the US. The urgency and the
scope of the problem prompt the development of solutions aimed to aid clinicians in reducing
such errors. Computer-based monitoring and alerting systems that rely on information in
electronic medical records (EMRs) play a key role in this effort. In the previous funding cycles,
our group has been developing an outlier-based model-driven alerting methodology with
significant potential to reduce medical errors. The method uses retrospective data to build
machine learning models that predict physician actions from a broad representation of patient
states. An alert is raised if a management action (or its omission) for the current patient deviates
significantly from predicted management actions for similar patients. As an example of an actual
alert generated by the system, consider a patient who has recently undergone a liver transplant
and receives tacrolimus as immunosuppressive agent. The patient suffers a complication and
undergoes corrective surgery; however, inadvertently, tacrolimus is not reordered following the
surgery. Since not receiving the expected medication represents a deviation from predicted
management practice in similar patients, it is a clinical outlier. Raising an alert to reorder the
medication is therefore appropriate. Our current alerting system is silently deployed on the
production electronic medical record system at UPMC and supports alerting in real-time.
The current proposal takes the research program in a bold new direction. Alerting models will be
enhanced using a variety of tools, including automatic evaluation of performance and the
inclusion of an adaptive ICU-specific knowledge-base in addition to multi-domain, multi-
resolution features derived from the EMR. Human experts will play a major role in determining
appropriateness and usefulness of alerts when generated in real-time, contribute to the dynamic
growth of the knowledge base, and evaluate the quality of the explanations provided for the
alerts. Finally, the alerting system will be deployed across 12 ICUs in a step-wedge clinical trial
to determine whether EHR-based alerting, when revealed to clinicians, modifies the rate and
timing of their actions. Secondary end-points will include alert performance metrics, process-
related outcomes, and patient-centered outcomes.

Public health relevance
Narrative The goal of this project is to evaluate a data and knowledge-driven, AI-based clinical alerting system. The system generates alerts in real-time on unusual clinical orders that could be medical errors. A clinical trial will be conducted to evaluate whether such AI-based alerting modifies the behavior of caregivers in the intensive care unit.